Predictive experiment-based multiscale models of the tumor immune microenvironment and immunotherapy in breast cancer

Project Summary
This research will focus on immunotherapy and the tumor microenvironment in breast cancer, and particularly
triple-negative breast cancer (TNBC), which is highly metastatic, has the worst prognosis among breast cancer
subtypes, and is lacking effective therapies. Immunotherapy is changing the paradigm of cancer treatment, but
in breast cancer the response rate to single agent immune checkpoint blockade is low, compared to more
immunogenic cancers. A quantitative understanding of the complexity of the immune-cancer interactions is
presently insufficient. The long-term goal of this project is to develop predictive, mechanistic clinically- and
experimentally-based computational models of breast cancer, taking into account the immune-cancer
interactions, and apply them to modeling cancer immunotherapy. The project will be a close collaboration
between computational, clinical, and experimental researchers. We will formulate quantitative systems
pharmacology (QSP) ordinary differential equation-based models comprising tumor (primary and metastasis),
lymph nodes, and blood and peripheral compartments; we will also formulate spatio-temporal three-
dimensional agent-based and hybrid tumor models that will describe tumor heterogeneity that is a hallmark of
cancer. Transport of ligands and drugs will be modeled by partial differential equations. The data for these
spatial models will be derived from our computational analysis of clinical pathology images where we will
determine the spatial distributions of immune cells, such as CD8+ T cells, regulatory T cells, and myeloid-
derived suppressor cells, and molecular markers such as PD-1, PD-L1, PD-L2, FoxP3, and LAG-3. The
distributions will be used to parameterize and validate the models; part of these data will serve as the input to
computational models and part for model validation. We will conduct state-of-the-art sensitivity analysis and
uncertainty quantification. The computer codes will be reported in the form to share with the research
community, to ensure reproducibility. The clinical data will be derived from several breast cancer
immunotherapy clinical trials in which immune checkpoints CTLA-4, PD-1, and PD-L1 are targeted, in
combination with immunomodulating agents, e.g. epigenetic. Clinical data will be supplemented with
experimental data obtained from syngeneic mouse models with orthotopic triple-negative breast cancer
tumors, with the experimental protocols mimicking the clinical trials. A variety of experimental methods will be
used to provide a plethora of data for model parameterization and validation, including flow cytometry,
immunofluorescence microscopy, protein arrays, and molecular biology. Additional immune checkpoints will be
explored experimentally and computationally, such as OX40 and LAG-3. The research will contribute to a
fundamental understanding of breast cancer biology, to the identification of potential biomarkers, and will aid in
design and interpretation of clinical trials. The synergistic combination of computational, clinical, and
experimental studies will provide significant insights into breast cancer immunotherapy.

Public health relevance
Narrative Breast cancer is the most commonly diagnosed female malignancy in the United States. Immunotherapy is changing the paradigm of cancer treatment. The goal of the project is to couple computational modeling with experimental studies in the laboratory and with clinical data to provide a better quantitative understanding of breast cancer and immunotherapy.